University of Utah Program to Provide Pain Research Knowledge (UP3RK)

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
To effectively address the nation's biomedical, behavioral, and clinical pain research needs, it is imperative to prepare an interdisciplinary pool of well-trained clinical pain research scientists. To accomplish this charge, the University of Utah Program to Provide Pain Research Knowledge (UP3RK) mission is to impart the science knowledge, skills, and core competencies needed by post-graduate, interdisciplinary Scholars to address the nation’s scientific needs in clinical pain research. UP3RK is situated at the University of Utah (UU), a rich environment to train interdisciplinary Scholars on clinical pain research across multiple settings. UP3RK training focuses on our institutional strengths of: 1) nonpharmacologic pain treatment; 2) effective interventions for pain and co-morbidities, particularly substance use disorders; 3) implementation science, and 4) research with varied populations of persons who experience chronic pain. Annually, UP3RK supports five Scholars—within a two- year training duration—through dedicated UP3RK Mentors within an innovative, multi-level mentor model (Mentor Matrix Model) that has proven extremely successful in developing independently-funded investigators who remain in academic research careers. The UP3RK trains our Scholars in: 1) in our four focus areas, 2) career development and programmatic skills, and 3) interdisciplinary research skills. UP3RK’s emphasis on communication, grant writing, and team science at all levels equip our Scholars with key knowledge, skills, and abilities to advance innovations to improve health for persons with chronic pain and enable a multi-disciplinary approach to team science. To accomplish our mission, we leverage new and existing local training curricula and national trainings available from the HEAL PAIN Cohort Program. We evaluate UP3RK training activities through a dedicated evaluation process. UP3RK program objectives are: 1) Recruit and support an interdisciplinary group of clinical pain research Scholars with particular emphasis on those with different career paths and clinical backgrounds, 2) Provide a state-of-the-art training environment and curriculum to develop the next generation of clinical pain researchers with emphasis on the UP3RK focus areas; nonpharmacological pain treatments; effective interventions for pain and co- morbidities, particularly SUDs; implementation science; and research within various populations of persons with chronic pain, 3) Provide Scholars with opportunities to improve the impact of their clinical pain research careers and achieve independent research support within 5 years of completing the UP3RK program by developing career development and programmatic skills (e.g., technical, operational, professionalism, communication skills) and interdisciplinary research skills (e.g., working with an interdisciplinary research team). The research environment and novel training opportunities available through the UP3RK will facilitate achieving these objectives and ensure the program develops Scholars with the characteristics of successful, independent clinical pain researchers.

Public health relevance
The University of Utah Program to Provide Pain Research Knowledge (UP3RK) mission is to impart the science knowledge, skills, and core competencies needed by post-graduate, interdisciplinary Scholars to address the nation’s scientific needs in clinical pain research. UP3RK trains Scholars through mentorship and concentrated training in: 1) our four focus areas (nonpharmacological pain treatments; effective interventions for pain and co- morbidities, particularly substance use disorders; implementation science; research with varied populations of persons who experience chronic pain), 2) career development and programmatic skills, and 3) interdisciplinary research skills. We train Scholars through dedicated UP3RK Mentors within an innovative, multi-level mentor model develop independent clinical pain investigators and successful academic research careers.